Mechanisms in Blood Clotting

Abstract
The overall vision is to create a detailed understanding of mechanisms that regulate the blood clotting system,
with a goal of elucidating the aspects of the clotting machinery that function differentially in hemostasis versus
thrombosis. The conceptual framework is that human thrombotic diseases result from an otherwise protective
mechanism (immunothrombosis) gone awry. In this view, hemostasis following vascular injury is driven by the
prompt exposure of blood to preexisting, natural procoagulants such as tissue factor and collagen that are
ubiquitous throughout the body and that induce rapid formation of hemostatic plugs. On the other hand,
immunothrombosis is likely triggered and/or greatly enhanced by the elaboration of damage-associated
molecular patterns (DAMPs) and pathogen-associate molecular patterns (PAMPs). An important concept is
that many of these PAMPs and DAMPs that drive immunothrombosis are potential therapeutic targets that
should have little or no involvement in normal hemostasis. In order to achieve this vision, we need to have a
much better mechanistic understanding of what regulates blood clotting reactions, and in particular we need to
identify and understand the DAMPs that drive thrombosis and coagulopathies. The proposed work will focus on
three general areas within this general conceptual framework: elucidating mechanisms by which procoagulant
anionic polymers such as polyphosphate (polyP) and nucleic acids trigger regulate blood clotting and
inflammation; identifying key structural details that control the function of the tissue factor/factor VIIa complex;
and achieving a detailed understanding of how phospholipid bilayers regulate blood clotting reactions. These
studies will build on our prior success in this area and will advance the field.

Public health relevance
Project Narrative (relevance of this research to public health): Our laboratory is studying recently discovered molecules that contribute to thrombosis—the formation of life- threatening, unwanted blood clots inside arteries or veins. These basic science studies have the potential to lead to new insights into how unwanted blood clots occur in heart attack, stroke and deep vein thrombosis. These studies may allow us to develop new treatments for diseases like thrombosis and hemophilia that are caused by improper functioning of the blood clotting system.